Mechanisms of CRISPR-mediated immunity and applications beyond editing

PROJECT SUMMARY/ABSTRACT
The discovery of CRISPR (Clustered Regularly Interspaced Short Palindromic Repeats) systems led to
creative new applications that are transforming science and medicine. However, the rapid discovery of new
CRISPR systems outpaces our understanding of their biological roles in anti-phage defense and their
development for novel applications. To acquire immunity to new phages, CRISPR-associated proteins (Cas1
and Cas2) integrate fragments of phage DNA ("spacers") at the "leader-end" of the CRISPR locus, near the
transcription start site. But how Cas1-2 recognizes the leader-end of the CRISPR remains poorly understood.
Next, the CRISPR locus is transcribed and processed into "guide RNAs" that are loaded into surveillance
complexes (i.e., Csm complex). Upon sensing viral RNA, the Csm complex makes cyclic oligonucleotide
messengers that regulate CRISPR adaptation and nucleases critical for phage defense. But the biological roles
of many of these immune effectors remain understudied. My preliminary bioinformatics analysis of CRISPR
leaders (upstream DNA) has revealed subtype- and microbe-specific motifs. These conserved motifs are found
in a tight distribution of positions relative to the leader-CRISPR junction, and positional variants are shifted by a
helical turn of DNA that would preserve the presentation of these motifs on the same "face" of DNA. In Aim 1, I
will determine the structures of biochemically trapped CRISPR integration complexes to determine the roles of
leader motifs and host proteins in regulating integration. In Aim 2, I will determine a biochemical and structural
understanding of immune proteins that I predict to be activated by CRISPR-generated nucleotide messengers.
This tailored application will support my transition to an independent academic position through: i) Structural
biology training, ii) Mentoring, communication, and grant writing training, iii) Identification of novel CRISPR
adaptation regulatory motifs and, iv) Identification of novel immune effectors. I will take formal cryo-EM
coursework provided at Montana State 'University's (MSUs) cryo-EM facility by co-advisor Dr. Lawrence and
co-mentor Dr. Lander, supplemented by coursework at NIH's National Center for Cryo-EM Access and
Training. I will further develop my mentoring, communication, and grant writing skills through coursework
provided by 'MSU's Center for Faculty excellence and by ASBMB's UE5 component. I have recruited a
mentoring and advisory committee of six scientists with complementary expertise in CRISPR biology, the
development of CRISPR-based applications, cryo-EM methodology, virology, and infectious diseases -
relevant to guiding me as I pursue my research and career goals. The proposed project provides me with
training in cryo-EM structural biology. It provides me with foundational bioinformatic and biochemical data that
will serve as a springboard for my independent lab's interdisciplinary research on CRISPR biology and its
applications. There, I aim to serve as a mentor for the next generation of underrepresented minority scientists.

Public health relevance
PROJECT NARRATIVE This proposal will determine structural and biochemical understandings of CRISPR adaptation and CRISPR immune signaling pathways. This research is relevant to public health because it will increase our knowledge about fundamental cellular processes, including the diverse mechanisms that govern new CRISPR spacer acquisition and the role of diverse immune effector proteins responsible for anti-phage defense. In addition, the proposed research is relevant to the mission of the NIH because it will provide critical insights into CRISPR biology necessary for applications in genetic recording devices, diagnostics, antimicrobials, and other areas of biotechnology and medicine.